FASEB SRC: The Biological Methylation Conference: Fundamental Mechanism in Human Health and Disease

Abstract (30 lines max):
The purpose of this R13 submission is to request funds for a limited number of junior invited speakers and
trainees from groups traditionally underrepresented to participate in the 2022 FASEB Science Research
Conference on “Biological Methylation”. This will be the 14th FASEB SRC of the series and will be held at the
Catania Sheraton Conference Center from June 19-23, 2022. The last FASEB meeting was held in Florence,
Italy in 2018, where Dr. Guccione and Dr. Schneider were elected as co-chairs to work jointly with Dr. Davies
and Dr. Ge who will be the two co-chairs for 2022. The conference was originally scheduled for 2020 and then
cancelled due to the pandemic. The 2022 conference builds upon the scientific excellence of previous meetings,
bringing together a diverse group of developmental and cancer biologists, chemists and computational biologists,
both clinicians and basic scientists, from academia and pharma. The venue and scientific program will foster
interaction between participants with different expertise and at different stages of their career. Previous
evaluations have ranked this conference highly for outstanding presentations, discussion time, collegial
atmosphere fostering mentorship and for the high impact speakers, who remain for the entire duration of the
conference. In addition, we commit to an increased number of abstracts selected from trainees and will provide
a platform for short presentations, poster sessions and sufficient free-time to foster collaborations.
The 2022 program covers all major areas of high interest in the field of biological methylation such as lysine and
arginine methylation, CpG methylation and novel RNA methylations. These are particular relevant fields of
research given the recent promising clinical studies on several small molecule inhibitors in cancer therapy. Other
sessions will deal with the structure and function of RNA, DNA and protein methyltransferases/demethylases,
and protein post-translational methylation. The attendees’ background is very diverse, giving a unique
opportunity to participants to interact with one another to further advance the basic understanding of biological
methylation and to understand how methyltransferases and demethylases may be therapeutically targeted. In
response to evaluation requests we have added several “meet the experts sessions” to discuss relevant issues
such as “women in science” and “mentorship and transition to independence”. In addition, we will organize a
Mini-symposium on “Small Molecule Inhibitors of methyltransferases and Demethylases”.
To summarize, the specific goals of this conference are to: 1) provide a forum for the presentation of unpublished,
cutting-edge research by investigators from diverse fields applicable to biological methylation, both from
academia and pharma; 2) provide an opportunity for scientists studying diverse aspects of the biochemistry,
function and disease relevance of SAM-dependent methylation, to discuss recent research developments and
to initiate collaborations; 3) ensure development and integration of young investigators from diverse backgrounds
and those traditionally under-represented in these fields into the broader research community.

Public health relevance
Project Narrative The goal of the 2022 FASEB SRC on Biological Methylation is two-fold: First, to bring together members with diverse expertise to bridge and foster translational research in the field of developmental biology, small molecule inhibitors and cancer. Second, to provide a supportive mentoring platform for trainees and junior investigators from diverse backgrounds, giving them opportunity to engage with those more established in their field.